Joint estimation of motion model, model parameters, and particle trajectories in single particle tracking

PROJECT SUMMARY: Single particle tracking (SPT) is a powerful class of techniques for understanding biomolecular motion at the subcellular level in the crowded environments of the plasma membrane, cytoplasm, and nucleus. The basic scheme is to acquire image sequences, typically through wide-ﬁeld ﬂuorescence imaging, produce trajectories from these images, and ﬁnally to estimate motion parameters from the trajectories through the use of tools such as curve-ﬁtting to the mean-square displacement (MSD) curve. The method has been extremely effective for the study of single particles moving in the plane under a ﬁxed model. SPT will have a transformative impact once it is capable of studying biological macromolecules moving in three dimensions and undergoing complex modes of motion that switch between different models during a single run as particles undergo, for example, internalization, recycling, and trafﬁcking between cells. In the 3-D setting, the assumptions that make the standard methods both simple and robust no longer hold and issues such as motion blur, ad hoc choices of ﬁtting parameters that have a large impact on the accuracy of results, an assumption of stationarity in the data which precludes analysis of mode switching in a single trajectory, separation of the analysis of particle trajectory from motion parameter estimation, and lack of modeling of effects of non-Gaussian noise must be addressed and overcome to make SPT as effective in 3-D as it has been in studying planar motion. The proposed project consists of three speciﬁc aims. The ﬁrst is focused on creating techniques for jointly estimating particle trajectory and motion parameters from SPT data sets using a framework that allows for complex motion and observation models, including camera-speciﬁc descriptions, depth-dependent point spread functions, and dynamics that switch between different models. The resulting method will greatly improve the accuracy and applicability of SPT in the 3-D setting. The second aim targets data acquisition, using a confocal- based tracking scheme inspired by nonlinear, stochastic extremum-seeking control. The confocal modality provides a better SNR, innate 3-D capability and, most signiﬁcantly, an extremely fast sampling rate to miti- gate effects of motion blur. The proposed method, implementable on standard confocal instruments, is tunable for optimal performance at different experimental settings and complements wide-ﬁeld techniques when high temporal resolution of a single particle is needed. Finally, the third aim seeks to validate the proposed tech- niques in two experimental systems. The ﬁrst is a simple setting of tracking quantum dots inside hydrogels. These polymer-based systems are extensively used in a number of biomedical applications, including tissue engineering, drug delivery, and immunoisolation. The second setting is that of tracking individual, labeled AMPA receptors in rat hippocampal neurons, providing a biological setting for validation and demonstration.

Public health relevance
PROJECT NARRATIVE This project aims to develop new methods for acquiring and analyzing data on the motion of single biological macromolecules. The methods will greatly improve the tools for understanding three dimensional dynamics in biomolecular systems, impacting our ability to understand basic biology and diseases at the cellular and sub-cellular level. Demonstration of the methods for tracking individual AMPA receptors in rat hippocam- pal neurons will validate that the techniques can be used to provide signiﬁcant insight into systems such as glutamate receptor microdynamics under both physiological and pathological conditions.